Administrative Core

Summary
The main objective of the Administrative Core of this Program is to provide support and
assistance to all scientists and administrative personnel participating in the four
Projects and two Scientific Cores of this Program Project. It is imperative that all teams
involved in this Program integrate seamlessly to establish a symbiotic unit, particularly
given the uniquely integral functions that each Project and Core Leader will provide to
the overall Program. Under the direction of Dr. Allis, his laboratory's administrator,
Marisa Cerio, will manage this core. Ms. Cerio has demonstrated experience in the
integration of many projects across institutions worldwide, including a well-established
and ongoing collaboration between all Project leaders outlined in this proposal!